Building normative models of Reinforcement Learning Decision Making Behavior

The main objective in the field of psychiatry is to be able to treat patients at an individual level. To reach this goal
of precision medicine, large scale initiatives such as the RDoC have been developed to find new ways to parse
heterogeneity in psychiatric disorders. Their success has been slow partly due to a slow transition away from
case-control studies based on diagnoses and limitations due to small sample size. Therefore, there is a critical
need to find alternative solutions at an affordable cost. One strategy is to identify a complex behavior such as
Reinforcement Learning based decision making (RLDM) that is impaired across various psychiatric disorders
and adopt a computational framework to explain heterogeneity at an individual level. RLDM is a multifaceted
construct involving several sub-processes ranging from estimating values of different options in the environment
(valuation), accumulating evidence for these options (sequential sampling), choosing the best option (explore-
exploit behavior), estimating the outcome value (salience attribution) and lastly integrating relevant information
about outcomes and updating the value of stimuli (learning rate). These sub-processes can be quantified by
utilizing computational models. However, prior to building normative models of these RLDM constructs that can
be potentially utilized in clinical practice, it is critical to assess the reliability of these RLDM model-derived
parameters to avoid translational failures. Therefore, our main goals of this proposal are to (1) parse RLDM sub-
processes into mathematically-defined parameters in a large sample using a diverse set of tasks; (2) assess
test-retest reliability of these parameters; and finally (3) build normative models of the parameters and chart the
heterogeneity at the level of the individual. To achieve this goal, we will acquire behavioral data from six RL
tasks, including delay and effort discounting, probabilistic learning, virtual patch foraging, Pavlovian instrumental
transfer and approach-avoid conflict tasks. These tasks are each optimized to measure at least two of the RL
sub-processes separately. We will collect behavioral data and self-report assessments from a community sample
from 1000 participants (aged 18-85). To estimate test-retest reliability of RLDM parameters, we will invite 500
healthy participants from this sample to complete the session again in one week’s time. First, we will apply start-
of-art computational models to quantify RLDM behavior in each subject. Second, we will calculate the test-retest
reliability of these parameters. Third, we will build normative models to link each of the RLDM construct with age
and calculate each subject’s deviation from the norm. Lastly, we will conduct soft clustering on these deviations
to identify clusters and investigate their differences in psychopathology and general functioning.

Public health relevance
Reinforcement learning Decision Making (RLDM), which encompasses a range of behaviors critical for survival, is impaired across various psychiatric disorders and symptoms. By acquiring a range of RLDM behavioral data from a large community sample with varying degrees of clinical symptomology, we aim to parse RL behavior into fine-grained mathematically defined constructs and build normative models to make predictions at individual- level. The proposed research aims to study RL behavior disorders at the individual level without parsing the clinical cohort, which could be the first step towards precision medicine by systematically mapping the heterogeneity of psychopathology based on behavior/transdiagnostic symptoms.